Ethanol-induced disruption of kinase signaling pathways in brain development

ABSTRACT
Fetal Alcohol Syndrome (FAS) is one of the leading causes of intellectual disability in the United States. The
CDC estimates that 0.2-1.5 per 1000 live births are children with FASD, a syndrome characterized by disrupted
fetal brain development and postnatal intellectual disability (ID). Disrupted connectivity including altered
dendritic structure, axonal pathfinding and white matter tracts are common findings in FAS and are thought to
be major contributors to ID. However, the cellular and biological targets of alcohol are diverse and it is not clear
whether there are common underlying molecular mechanisms producing these disruptions. Identification of
common molecular mechanism(s) would enable a deeper understanding of this disorder, inform studies of
genetic susceptibilities and provide molecular targets for neuroprotective strategies. This proposal pursues our
finding that acute ethanol (EtOH) exposure disrupts Src kinase activity in embryonic cortical neurons. Src is a
critical non-receptor tyrosine kinase that sits at central positions in multiple signaling pathways including the
Reelin-Dab1 signaling pathway which controls brain layer formation and dendritogenesis. We found that acute
EtOH exposure activates Src and induces phosphorylation of many proteins including Dab1, an essential
adaptor protein in the Reelin-signaling pathway. Remarkably, this dramatic increase in phosphorylation is
followed by a sustained dephosphorylation response in which the phosphorylation of Reelin effectors including
Dab1, Src itself and the actin severing protein n-cofilin return to baseline levels, or below. During the extended
dephosphorylation phase, the Reelin-signaling pathway can no longer be activated by in vitro application of its
ligand, Reelin. In AIM 1 of this proposal, we will determine whether Reelin-Dab1 silencing occurs in vivo after
maternal dosing with EtOH. We will then determine whether genetic deficiency in Src prevents the
phosphorylation and dephosphorylation responses. Genetically establishing the critical kinase that initiates the
EtOH response in vivo will be essential for future neuroprotective efforts. We and others have shown that
Reelin-Dab1 signaling controls Golgi-deployment in the forming dendrite. In AIM 2 we will examine whether Src
activation and inactivation disrupts Golgi location and function. Disrupted Golgi function would be expected to
impact membrane addition, glycosylation, secretion and appropriate expression of many proteins, with
potential long term negative consequences on neuritogenesis and neuronal function. In AIM 3 we will
determine whether the EphA3 signaling pathway is similarly disrupted by Src dysregulation. EphA3 is a
receptor tyrosine kinase that is required for axonal and white matter tract development. We identified the
activation site of EphA3 as a target of EtOH-induced Src dysregulation raising the possibility that EphA3
activation and then silencing may contribute to FASD-related white matter disruptions. Collectively, these
studies will determine the contribution of EtOH-dependent Src dysregulation to altered developmental signaling
in pathways critical for brain development.

Public health relevance
NARRATIVE Fetal alcohol syndrome disorder (FASD) is a leading cause of intellectual disability in the United States and is due to maternal alcohol consumption during pregnancy. While the neurodevelopmental disruptions caused by prenatal alcohol exposure are diverse, disrupted axonal and dendritic growth (brain wiring) is a consistent finding. In this proposal we test the novel hypothesis that the wiring defects are caused by dysregulation of a tyrosine kinase called Src making this enzyme a target for neuroprotective strategies.